The role of neuroimmune interactions in the pathogenesis of chronic pain

Project Summary/Abstract
Nerve injury-induced neuropathic pain is a major health problem with limited treatment. Insufficient
understanding of this disorder at the level of neural circuits impedes the development of effective therapies.
The activation of the immune system and neuronal alterations in the somatosensory pathway are known to be
critical for the genesis of neuropathic pain. However, how immune cells interact with neurons after peripheral
nerve injury and contribute to persistent and intense pain sensation remains largely elusive. Our recent studies
have shown that monocytes and microglia synergistically promote the development of neuropathic pain
symptoms. We have also developed novel approaches for imaging and manipulating neurons and nonneuronal
cells (e.g. monocytes, microglia and astrocytes) in the pain pathway, from peripheral dorsal root ganglia (DRG),
the primary somatosensory cortex (S1) to anterior cingulate cortex (ACC) in the awake, behaving mice. In our
preliminary studies, we have found that following peripheral nerve injury, DRG sensory neuron activities
undergo rapid and transient increases whereas pyramidal neuronal activities in the S1 and ACC rise
progressively and remain elevated under chronic pain states. Moreover, selective depletion of microglial
cytokine TNF-alpha production attenuates pain hypersensitivity after nerve injury. Based on these findings, we
hypothesize that the interactions among peripheral monocytes, brain microglia and astrocytes play critical roles
in the emergence of hyperactive neurons in the cortex during the transition from acute to chronic pain. In this
application, we will test this hypothesis by combining in vivo two-photon imaging of synapse structure and
neuronal activity, genetic manipulation of molecularly defined cell types in cortical circuitry, as well as
behavioral testing for sensory and affective pain symptoms. Specifically, in Aim 1, we will characterize the
sequential changes of neuronal activities in the pain circuits after peripheral nerve injury. This will test the
hypothesis that dynamic changes in pain circuits occur progressively from the DRG to the cortex and that
persistent neuronal hyperactivity emerging in S1 and ACC is critical for the induction of chronic neuropathic
pain. In Aim 2, we will combine in vivo calcium imaging with in vivo cell depletion and bone marrow chimeric
strategies to investigate the synergistic roles of monocytes and microglia in the emergence of persistent
cortical hyperactivity. In Aim 3, we will test the hypothesis that monocytes/microglia promote nerve injury-
induced neuronal hyperactivity via proinflammatory cytokines and astrocytes in the cortex. Together, our
proposed research will significantly expand the knowledge on the contribution of neuroimmune interactions to
the development of neuropathic pain. They will also help identify immune cells as novel targets for the
development of effective pain therapies.

Public health relevance
Project Narrative Chronic neuropathic pain affects millions of people and is difficult to treat. This project will use animal models to investigate changes of neurons and nonneuronal cells in the pain circuits during the initiation and progression of neuropathic pain after peripheral nerve damage. Results from this proposed project will provide important insights into the role of neuroimmune interactions in neuropathic pain etiology, and identify novel therapeutic targets for the prevention and treatment of neuropathic pain.